Exploring a Novel Myeloid Subset for Transporting Polyomavirus to the CNS

Abstract
JC polyomavirus (JCPyV) is the causative agent of the often-fatal demyelinating brain disease Progressive
multifocal leukoencephalopathy (PML). While 70-90% of adults carry JCPyV lifelong, only after
immunosuppression is the virus able to travel from the primary infection reservoir in the urinary tract to the
central nervous system. How the virus traffics to and enters the brain is unknown. Utilizing the mouse
polyomavirus (MuPyV), a natural mouse pathogen, I have employed Fluorescence-activated cell sorting
(FACS), RT-qPCR, flow cytometry, and immunofluorescent imaging to phenotype a subset of macrophages
with activity replicating MuPyV. These macrophages are express CD13 and are found in the spleen, brain, and
blood. These CD13+ myeloid cells possess unique expression of surface markers compared to other
macrophages in the tissues. Notably, CD13- macrophages do not support MuPyV infection. Our published data
suggests that the ependyma, a multi-ciliated single-cell layer lining the cerebral ventricles, may be a site of
entry into the brain parenchyma. Our lab has found that the ependyma supports productive MuPyV infection.
The ependyma is contiguous with the choroid plexus epithelium, which supports JCPyV infection. By
immunofluorescence microscopy, I visualized CD13+ macrophages at the ependyma in uninfected mice.
Monocytes/macrophages enter at this blood-CSF barrier as part of cell population homeostasis. I have found
that CD13+ monocytes also selectively support MuPyV infection. These results together suggest that CD13+
macrophages are a candidate for MuPyV trafficking to the central nervous system.

Public health relevance
Project Narrative JC Polyomavirus can cause debilitating and often fatal brain diseases. This fellowship will explore this CNS infection modeled in vivo with Mouse Polyomavirus to address the current gap of how the virus traffics from the common reservoir in the urinary tract to the brain. Specific myeloid cell subsets, such as CD13+ macrophages, demonstrate potential for supporting active virus replication and facilitating entry at the brain barrier sites of the choroid plexuses and ependyma.